NIH Training Grant in Chemistry-Biology Interface

PROJECT SUMMARY: The goal of this Chemistry-Biology Interface (CBI) training program is to prepare 10
predoctoral students to become next-generation scientists in the biomedical sciences. This goal will be
achieved through recruiting top students and training them in cross-disciplinary research, critical thinking,
writing and communication, rigorous experiment design and interpretation, and responsible conduct of
research. Other distinctive components of the program are: a) a course on cutting-edge research at the CBI, b)
workshops on entrepreneurship, intellectual property management, and networking, and c) participation in
Peer-Led Team Learning (PLTL) experiences, which will further enrich the skillset and professional preparation
of the trainees. The program will directly benefit from the close research relationship and physical proximity
between Arts, Sciences, & Engineering (AS&E) and the School of Medicine and Dentistry (SMD) at the
University of Rochester, and its established record in innovation and entrepreneurial translation of scientific
discoveries into new businesses. The program includes 27 outstanding preceptors selected from six
departments within AS&E and SMD, all of whom have a strong record of intra- and interdepartmental
interactions in research and mentoring activities. A central theme of the program, as shared by the research
interests of the preceptors, is the development of fundamental knowledge and strategies to support the
generation, development, and delivery of new therapeutic agents and modalities for the prevention and
treatment of human diseases. Trainees will conduct research in one of the four main areas around this unifying
theme: Synthetic Chemistry, Drug Discovery & Delivery, Drug Target Identification and Sensing, and Structure
and Function of Biomolecules & Biomaterials. The Program Director and two Deputy Directors will be aided by
a Steering Committee comprising three additional faculty members. The CBI trainees will be drawn from the
strongest students in the participating departments, with a particular emphasis on expanding trainee diversity
through outreach activities, recruiting a diverse pool of applicants, and retaining and nurturing students in the
program. New CBI trainees will start in Year 2 of their graduate studies and will participate in the core CBI
courses, a course on responsible conduct of research, and a course on effective writing and communication.
All trainees will participate and contribute to a host of CBI-sponsored enrichment and synergistic activities,
including professional development workshops, an annual retreat, and monthly CBI lunches. In Year 4 of their
PhD program, trainees will serve as PLTL workshop leaders for CBI courses, continue in professional
development, and present a talk at the CBI retreat. Trainees also will complete and defend their theses
supervised by one of the CBI preceptors. It is expected that students completing this program will be
exceptionally well prepared to pursue a variety of careers in the life and biomedical sciences. Success in this
program will also be determined by increased diversity of trainees and in the pool of applicants.

Public health relevance
PROJECT NARRATIVE This program will attract and train a cohort of top graduate students at the interface of chemistry and biology. This training will prepare them for diverse career paths in research and entrepreneurship in the life science, and equip with additional training and experience in teaching and communication of chemistry/biology science. Ultimately, this program will contribute to an improved understanding of human health and new treatments for diseases.